Protocol Review and Monitoring System

PROTOCOL REVIEW AND MONITORING SYSTEM (PRMS)
PROJECT SUMMARY/ABSTRACT
The PRMS at the Rutgers Cancer Institute of New Jersey (CINJ) is composed of three components, the Disease
Specific Groups (DSGs), the Scientific Review Board (SRB), and the Human Research Oversight Committee
(HROC). These groups work collaboratively to provide oversight of all aspects of oncology clinical research at
CINJ, across the RWJBarnabas Health (RWJBH) system. Since January 2019, RWJBH leadership agreed that
all oncology research at any of the system hospitals would be conducted in accordance with our CCSG
processes and under CPDM oversight, as memorialized in a memo executed by Howard S. Hochster, MD, FACP
as Associate Director for Clinical Research and Steven K. Libutti, MD, FACS as Senior Vice President of
Oncology Services. All cancer research throughout the RWJBH system is now reviewed by the SRB and under
the supervision of the CINJ PRMS. Each of the 13 DSGs is responsible for the initial review and prioritization of
interventional trials within its portfolio as well as the ongoing scientific relevance of the trial to the disease area,
regardless of the PI or hospital where the PI practices. DSG review and written approval are required for any
interventional therapeutic trial in order to be reviewed by the SRB. The SRB focuses on scientific merit, scientific
prioritization for CINJ resources, and ongoing scientific progress of the trials. To provide the necessary expertise
in the principal disciplines of oncology, the SRB consists of clinical, basic, and population scientists,
biostatisticians, community outreach engagement specialists, and patient advocates. By agreement with Rutgers
Biomedical Health Sciences (RBHS), the SRB must review all cancer-related clinical protocols before
Institutional Review Board (IRB) review; this provides a centralized mechanism for evaluating the scientific merit
of all cancer clinical trials and prioritizes studies for access to CINJ resources. COE community outreach
specialists review each protocol reviewed by SRB to ensure appropriate representation by gender, race,
ethnicity, and age in each interventional trial, making approval and enhancement recommendations. Patient
advocates review each protocol for advice on patient acceptability. The SRB reviews the CINJ Data and Safety
Monitoring Plan (DSMP) and assigns the level of risk to interventional, investigator-initiated trials (IITs).
The SRB works with HROC, which functions as an independent Data and Safety Monitoring committee
responsible for safety review and accrual/progress monitoring of all CINJ IITs. All DSMP activities fall under the
purview of HROC and are further described in the Clinical Protocol and Data Management section. HROC reports
directly to the Cancer Center Director. HROC shares its findings and recommendations with the SRB in the event
that these are believed by the HROC to be potentially relevant to the scientific integrity of the trial. SRB reviews
these findings and recommendations and has the sole authority to close any trials that are not meeting accrual
or performance standards. Importantly, in the event that the committee is notified of misconduct or other issues,
the SRB will contact all appropriate authorities (e.g., IRB, FDA, NCI, funding sponsor) as needed.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)